Molecular and Cellular Phenotyping (MCP) Core

PROJECT SUMMARY (MOLECULAR AND CELLULAR PHENOTYPING CORE)
As a major research core component of UNH’s COBRE: Center of Integrated Biomedical and
Bioengineering Research (CIBBR), the overall goal of the Molecular and Cellular Phenotyping (MCP) Core is
to enable new technologies that translates rigorous multidisciplinary research into biomedical and
bioengineering solutions while judiciously managing the MCP Core research infrastructure to ensure long-term
sustainability. The Phase 2 objectives are to: (1) Appoint CIBBR faculty with the appropriate expertise to serve
as Assistant Core Directors to the three MCP sub-cores (Cellular Biology, Molecular Biology, and BioAnalytics)
to boost scientific guidance, core management, and user bases; (2) Acquire three major instruments (a super-
high resolution Nikon STEDYCON module for the Nikon A1R confocal microscope, a Bruker timsTOF Pro2
LC-mass spectrometer system, and a Pavine nanoindenter) to expand research capacity and expertise in
super-high resolution imaging, proteomics, and the mechano-deformability of biomaterials—all of central
relevance to CIBBR investigators and the UNH and external research community; (3) Provide user training,
workshops and support (in conjunction with the CIBBR Data Science Core) to encourage and enable the use
of contemporary instrumentation and techniques, expand user bases, and ensure scientific rigor and
reproducibility; (4) evolve and implement a business plan increases instrument utilization and integrates
mechanisms for infrastructure sustainability of the MCP Research Core.
Upon completion of the above objectives, the MCP Core will have advanced the capabilities, expertise,
user base, management, and sustainability of the biomedical research infrastructure available to CIBBR, UNH
and regional researchers. The MCP Core will also provide opportunities for CIBBR investigators to advance
their research programs, while acquiring new skills and knowledge that bolster CIBBR’s impact and
sustainability. Together, this will heighten the productivity of CIBBR-supported research programs and other
MCP Core users, while effectively promoting the translation of research knowledge to enhance human health.